Design and testing of germline-targeting and boosting immunogens to elicit 10E8-like broadly neutralizing antibodies against HIV

Induction of broadly neutralizing antibodies (bnAbs) is a critical unmet goal of HIV vaccine
development. BnAb 10E8 is of particular interest as a vaccine lead due to its (1) very high
breadth, (2) low number of mutations required to develop broad neutralization, (3) low
auto-reactivity, (4) expected high frequency of precursors in the human na'ive B-cell pool and (5)
ability to provide surprisingly potent in vivo sterilizing protection in passive transfer studies.
Key challenges for inducing 10E8-like bnAbs are: (a) the low germline affinity by HIV peptides and
proteins, (b) the severe restriction on bnAb angle of approach imposed by the recessed,
membrane-proximal epitope environment and (c) the absence of the 10E8 epitope from most soluble,
native-like trimers (e.g. SOSIP or NFL or UFO).
A promising strategy to initiate 10E8-like bnAb induction is germline targeting, in which suitable
10E8-class precursors are specifically activated using engineered immunogens, thus selecting BCRs
with the potential to develop broad neutralization in the absence of autoreactivity. This approach
will also help circumvent steric problems associated with the recessed location of the epitope, by
priming precursors with known genetic and structural potential to mature into bnAbs compatible with
MPER steric restraints. In this proposal, we will engineer epitope-scaffold immunogens that
activate 10E8-like precursors, using computational design and directed evolution. We will initially
test immunogens ex vivo using human na'ive B cell sorting. We will further generate knock-in mice
that over-express 10E8-like precursors, and we will use those mice to test B-cell priming and
boosting in vivo, first adoptively transferring knockin B cells to wild- type mice in order to
mimic frequencies of 10E8 bnAb precursor and competitor B cells in humans.
As known bnAbs are highly mutated, vaccine induction of bnAbs following a germline prime will
likely require sequential immunization with other immunogens designed to shepherd affinity
maturation of the B-cell receptor. We will develop different classes of boosting immunogens,
including epitope-scaffolds with more native epitopes, membrane-protein scaffolds and
membrane-bound Env variants stabilized in a conformation to which 10E8 binds strongly. We will
conduct sequential prime/boost immunization experiments in knock-in mice and use ELISA, cytometry,
single B-cell sorting and sequencing and neutralization assays to track and optimize affinity
maturation.
In summary, these studies seek to develop novel HIV vaccine candidates and also to
shift HIV vaccine research towards a reductionist approach based on strategic
identification of bNAb precursors, state-of-the-art protein engineering to develop
germline-targeting and boosting immunogens, development of human Ig knock-in mouse models to enable
testing of human-repertoire-specific vaccines, and in-depth analysis of vaccine-induced affinity
maturation pathways in vivo to guide iterative vaccine optimization.

Public health relevance
An optimal HIV vaccine will likely need to elicit multiple different types of broadly neutralizing antibodies (bnAbs) targeting multiple epitopes on the HIV glycoprotein trimer. A promising strategy to elicit bnAbs involves designing sequences of vaccine immunogens to first activate bnAb precursor B cells and then guide their affinity maturation to elicit broad neutralizing activity. In this proposal we will design such vaccine regimens to elicit one particularly promising class of HIV bnAb and we will test and optimize our vaccines in knock-in mice that we engineer to produce human germline- precursor B cells.